TRAINING IN MASS SPECTROMETRY BY THE YATES LAB IN 2009-2010

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Three graduate students from Brazil were trained by the Yates lab.